Phthalates, oxidative stress, and hot flashes in aging women

Hot flashes are transient periods of intense heat in the upper body, arms, and face that are often followed by
flushing of the skin, profuse sweating, chills, palpitations, and anxiety. Hot flashes pose a significant public health
concern because they are the most common perimenopausal symptom reported by women in the U.S., affecting
4-5 million women each year. For more than half of these women, hot flashes last more than 7 years and some
have hot flashes for up to 30 years. In addition, hot flashes negatively impact quality of life and lead to increased
health care expenditures. Despite the importance of hot flashes in women's lives, little is known about their risk
factors. Other than a few studies on cigarette smoking and one study on organic solvents, no studies examined
the association between environmental chemical exposures and hot flashes in women. Thus, we conducted
preliminary studies to examine whether exposure to phthalates is associated with an increased risk of hot flashes
in a cohort of 782 midlife women. We focused on phthalates because they are one of the top contaminants
present in human tissue and are used in a myriad of consumer products. Our data indicate that phthalate
exposure is significantly associated with an increased risk of having recent and frequent hot flashes in midlife
women. In fact, the degree of association is similar to that observed with cigarette smoking, one of the best
known risk factors for hot flashes. Although our data clearly indicate that phthalate exposure is associated with
a higher risk of hot flashes, we do not understand the underlying mechanisms. Published studies indicate that
phthalate exposure increases oxidative stress in animal models and a few small epidemiological studies suggest
that oxidative stress increases the risk of hot flashes. Thus, the overall goal of the proposed study is to test the
hypothesis that a cumulative mixture of phthalates is associated with increased risk of hot flashes via oxidative
stress pathways. We will test this hypothesis by completing the following specific aims: 1) prospectively
determine if cumulative exposure to a mixture of phthalates is associated with validated biomarkers of oxidative
stress in midlife women, 2) prospectively determine if validated biomarkers of oxidative stress are associated
with hot flashes in midlife woman, and 3) explore whether observed associations between urinary phthalate
metabolite concentrations and hot flashes are mediated by biomarkers of oxidative stress. This work may lead
to the development of better strategies to prevent and treat perimenopausal hot flashes, a condition that goes
untreated in the majority of women experiencing symptoms despite seeking medical treatment. Given the known
risks associated with current treatments for hot flashes (e.g., cancer, blood clots, stroke), new treatments could
be critical for this prevalent health outcome.

Public health relevance
The results of this study will provide a better understanding about the mechanisms by which environmental chemicals are associated with hot flashes in women. This ultimately may lead to the development of preventive strategies and/or new treatments for hot flashes in women.